Toolkit for Optimal Recovery after Orthopedic Injury; A multi-site feasibility study to prevent persistent pain and disability

PROJECT SUMMARY/ABSTRACT
The purpose of this research project is to provide research and career development training for Mr. Terence M. Penn, an
incoming postdoctoral fellow in the Center for Health Outcomes and Interdisciplinary Research (CHOIR) within the
Department of Psychiatry at Massachusetts General Hospital. This administrative supplement, in response to PA-21-071
“Research Supplements to Promote Diversity in Health-Related Research (Admin Supp),” will expand the parent project
“Toolkit for Optimal Recovery after Orthopedic Injury; A multisite feasibility study to prevent persistent pain and disability”
(R01AT010462, formerly U01AT010462; Overall PI Ana-Maria Vranceanu, PhD). The supplement will support the
postdoctoral education, research, and mentoring activities for the candidate, Mr. Terence M. Penn, MA, with the overarching
goal of developing him into an independent investigator specializing in mind-body intervention development and clinical
trials to prevent chronic pain among underserved minorities (URMs). The primary objective of the proposed research is to
understand barriers and facilitators for implementation of the Toolkit for Optimal Recovery study within the Boston Medical
Center’s (BMC) Level 1 orthopedic trauma center that treats underserved individuals who are in larger racial and ethnic
minorities. Thus, we will conduct focus groups with a) patients with recent orthopedic trauma (within 1-2 months of injury)
at risk for persistent pain and b) health care providers (i.e., surgeons, fellows, and residents) and support staff (i.e., nurses,
medical assistants) to synthesize strategies to recruit and retain individuals from underserved populations. The career
development component of this administrative supplement will enhance Mr. Penn’s research potential and capabilities to
pursue an independent research career in intervention development, chronic pain, and minority health outcomes. This will
be accomplished through a series of didactic and experiential training activities, which will be overseen by Mr. Penn’s
mentor, Drs. Ana-Maria Vranceanu with support from Dr. Paul Tornetta, Chief of Orthopedic Trauma at BMC. Mr. Penn’s
training will be supported by the rich resources at HMS/MGH including the Community Access and Research Center
(CARE). Completion of the proposed research and training plan will equip Mr. Penn with a unique combination of skills
pertaining to community engaged research, qualitative and mixed methods research, and grant writing. This expertise,
combined with his advanced training in clinical psychology, will provide Mr. Penn with distinctive capabilities to pursue
his own independent and systematic line of research in the future.

Public health relevance
Project Narrative Musculoskeletal injuries (i.e., orthopedic traumatic injuries) disproportionally impact underserved minorities. Within our parent R01 we are limited by an available participant sample of primarily White Non-Hispanic individuals. This administrative supplement will allow us to develop the necessary infrastructure to support adding Boston Medical Center (>50% underserved patient population) as a site during the future UH3/UG3, while also providing Mr. Penn with the necessary training in qualitative methods, community engaged research and orthopedic pain to support his transition to independence.